Exploring affect-motivated alcohol use as a value-based decision-making process

PROJECT SUMMARY/ABSTRACT
K99 training: The goal of the proposed K99/R00 Pathway to Independence Award is to provide Dr. Jonas
Dora with training needed to launch his career as an independent scientist. Following his PhD in cognitive
psychology, Dr. Dora has already started to make important contributions to the field of alcohol use research
as a postdoctoral research fellow in the Department of Psychology at the University of Washington. The
proposed K99 training period builds on Dr. Dora’s PhD background and his current training in the study of
alcohol use in natural environments. The K99 phase will provide a period of intensive training in the combined
study of alcohol use with experimental, ecological momentary assessment, and computational approaches,
and will position Dr. Dora to make substantial contributions to the field of alcohol research over the course of
his career. Dr. Dora will learn from the proposed mentor (Dr. Kevin King), local collaborators (Drs. William
George, Mary Larimer) and external collaborators (Drs. Matt Field, James Murphy, Katie Witkiewitz), who are
leading experts in the field of alcohol use research using both experimental and ecologically valid approaches,
as well as the advanced computational modeling of behavioral and subjective data. In addition, Dr. Dora will
attend courses, scientific conferences, and workshops to meet his training objectives. The University of
Washington is a world-class research institution that provides an optimal environment, the necessary
resources, and a stimulating intellectual space to facilitate successful completion of this project.
K99 research: Together with his mentor and collaborators, Dr. Dora will conduct controlled experiments in a
simulated bar environment as well as studies in people’s natural drinking environment to test the idea that
negative and positive reinforcement of alcohol can be observed when heavy drinkers with and without
symptoms of alcohol use disorder (AUD) make decisions between alcohol and substance-free reinforcers.
R00 research: Dr. Dora will translate the K99 research using a task involving hypothetical choices between
alcohol and substance-free reinforcers into an ecologically valid test of the hypothesis that positive and
negative affect differentially motivate real-world value-based decisions to consume alcohol (vs regulate affect
via alternative emotion regulation strategies) in heavy drinkers with/without symptoms of AUD in everyday life.
Significance: By combining methods from cognitive psychology and alcohol use research, this research will
provide a novel test of the idea that alcohol use is reinforcing in the face of positive and negative emotions, and
in that way will advance NIAAA’s strategic aim to identify mechanisms that contribute to AUD. By studying
alcohol use as a form of value-based decision-making, the insights from this project will suggest new
possibilities to target people’s emotions in the prevention and treatment of alcohol use disorder.

Public health relevance
PROJECT NARRATIVE Empirical data have not provided strong evidence that people consume alcohol in response to the experience of negative emotions in everyday life, despite theoretical predictions and evidence from cross-sectional and retrospective data to the contrary. The proposed study will employ a combination of innovative experimental and ecologically valid approaches to explore affect-motivated drinking as a decision that depends on the value assigned to alcohol relative to the value assigned to alternative substance-free reinforcers (e.g., consuming appetizing food) in emotional situations. Findings will improve our understanding of whether, when, how, and for whom alcohol use is reinforcing in everyday life, which will inform future prevention and treatment efforts attempting to help people reduce their problematic alcohol use.